DCC CANDIDATE TUMOR SUPPRESSOR GENE IN NEUROBLASTOMA

DESCRIPTION: (adapted from the investigator's abstract) The deleted in colorectal cancer (DCC) gene is a candidate tumor suppressor that is unique in its similarity to the neural cell adhesion molecule (NCAM) family of proteins. It has been implicated in a variety of malignancies on the basis of allelic loss and/or loss of expression, and recent functional studies have provided evidence of its presumed tumor suppressor role. Several factors have suggested that DCC may be important in neuroblastoma and also that neuroblastoma may be a particularly good system in which to advance our understanding of DCC. Unlike epithelial tissues, DCC is highly expressed in neural tissue, and several studies have implicated DCC in neural development and cellular differentiation. More specifically, we have recently shown that DCC protein expression was absent in 37% of 62 primary tumors, and the DCC(-) subset of tumors was associated with disseminated disease. In addition, an independent study has demonstrated 31% (n=81) 18q allelic loss using a marker within the DCC gene. These studies support the central hypothesis of this proposal that DCC may function as a tumor suppressor in the development of neuroblastoma. These studies will focus largely on the important issue of the function of the DCC protein and take several approaches to this problem. A second goal will be studies of DCC allelic loss and expression in the same tumor panel, an attempt to link the genetic and expression data that have implicated DCC in the development of neuroblastoma. The following specific aims are proposed: Specific Aim 1. Characterization of the function of the DCC protein. Aim 1a. Generation of DCC-transfected neuroblastoma cell lines using both constitutive and inducible promoters. Aim 1b. Determination of the role of the DCC protein in neuroblastoma tumor suppression. Aim 1c. Determination of the role of the DCC protein in neuroblast differentiation in vitro. Aim 1d. Initial studies of the DCC:netrin functional interaction in neuroblastoma cells. Specific Aim 2. Correlation of 18q allelic loss and DCC expression in neuroblastomas.